Chromatin regulation of neuronal activity-induced enhancer priming and epigenetic memory

Summary: Neuronal activity-induced gene expression is essential for converting transient stimuli into long-term
changes in brain function by modulating synaptic activity, neuron morphology, circuit formation, and behavioral
adaptation. Neural plasticity relies on the proper induction of activity-regulated genes (ARGs) through activated
Ca2+ signaling cascades and downstream transcription factors and chromatin regulators. We demonstrated for
the first time that previous stimulation of ARGs can prime the genes, resulting in faster and more robust
expression upon subsequent stimulation, possibly due to epigenetic memory. Intriguingly, it has been reported
that cocaine induces gene activation and epigenetic priming in the reward circuit in vivo, which could share
similar epigenetic mechanisms as in our experimental systems. The key question is how chromatin regulators
prime ARG enhancers at a poised state after a transient neuronal stimulation, leading to stronger response to
subsequent stimulation even after an extended period. Mammalian SWI/SNF-like chromatin remodeling BAF
complexes, containing core ATPase subunits BRG1/SMARCA4, play significant roles in signaling-induced
transcription. Mutations in BAF subunits are associated with neurodevelopmental or psychiatric diseases. We
have shown that BRG1 regulates ARG induction by controlling both enhancer chromatin environment and E/P
looping. Importantly, we identified a serine phosphorylation site in BRG1, induced by various neuronal stimuli
through Ca2+ signaling, which is crucial for ARG enhancer activation. Using mice with BRG1 knock-in phospho-
mutations, we demonstrated that BRG1 phosphorylation promotes ARG priming. Cohesin mediated 3D genome
reprogramming was identified as a potential priming factor regulated by activity-induced BRG1 phosphorylation.
Thus, we hypothesize that neuronal activity-induced BRG1 phosphorylation regulates enhancer priming and
epigenetic memory through establishing a cohesin-mediated primed state of chromosome 3D structure. We
propose three aims to test this hypothesis. We propose three aims to test this hypothesis. (1) Determine how
neuronal activity-induced BRG1 phosphorylation regulates enhancer priming through establishing a cohesin-
mediated primed state of chromosome 3D structure. (2) Determine the function of cohesin in BRG1
phosphorylation dependent ARG enhancer priming. (3) Examine the function of BRG1 phosphorylation in
regulating cocaine-induced gene activation and priming. Our study will provide significant insights into both the
epigenetic mechanism of neural plasticity and the molecular functions of chromatin regulators in neural disorders.

Public health relevance
PROJECT NARRATIVE: Neuronal activity-regulated genes (ARGs) are pivotal in transforming transient stimuli into enduring changes in brain function, and their priming is crucial for neural plasticity and drug addiction. Our recent work uncovered a dynamic phosphorylation site within the chromatin remodeler BRG1, which is associated with brain disorders and is essential for both ARG induction and priming. Using novel genetic tools and genomic approaches, we aim to delve into the mechanistic aspects of BRG1 phosphorylation, focusing on its role in ARG priming and its involvement in neural plasticity.